Core D - Cell Culture

Core D Cell Culture Project Abstract The goal of the work described in this proposal is to collect epithelial cells that line the surfaces of the nose and upper airways of human subjects with asthma or cystic fibrosis. The airway epithelial cells can be grown in the laboratory under conditions that allow large-scale expansion of cell number and frozen for storage and distribution to project investigators. Each sample can be thawed and further expanded for study and testing. Most human airway epithelial cells currently available for study are from transplanted disease lungs or lung donations not suitable for transplant. Collection of nasal and bronchial cells by brushing the epithelial surface is simple and safe, and allows us to obtain cells from a much larger pool of subjects. The ability to collect, expand, and distribute airway epithelial cells to researchers will have a positive impact on understanding and developing therapies for common airways diseases and provide an opportunity to test newly developed drugs for cystic fibrosis on rare mutations carried by only a few individuals.

Public health relevance
Core D Cell Culture Project Narrative The goal of the work described in this proposal is to collect epithelial cells that line the surfaces of the nose and upper airways of human subjects with asthma or cystic fibrosis. The airway epithelial cells can be grown in the laboratory under conditions that allow large-scale expansion of cell number and frozen for storage and distribution to project investigators. Each sample can be thawed and further expanded for study and testing. Most human airway epithelial cells currently available for study are from transplanted disease lungs or lung donations not suitable for transplant. Collection of nasal and bronchial cells by brushing the epithelial surface is simple and safe, and allows us to obtain cells from a much larger pool of subjects. The ability to collect, expand, and distribute airway epithelial cells to researchers will have a positive impact on understanding and developing therapies for common airways diseases and provide an opportunity to test newly developed drugs for cystic fibrosis on rare mutations carried by only a few individuals.